The Lymphoma Epidemiology of Outcomes (LEO) Cohort Study (Diversity Supplement - Mazie Tsang)

PROJECT SUMMARY
In 2020, an estimated 77,240 people in the US will be diagnosed with non-Hodgkin lymphoma (NHL), and
19,940 will die from this cancer. NHL incidence rates increased over the last half of the 20th century and only
recently stabilized. In parallel, NHL survival rates began improving in the mid-1990s with the advent of
improved treatment strategies, leading to the current 5-year survival rate of 74%. These trends have led to a
growth in the number of NHL survivors, estimated at over 757,000 in 2019. To address the unmet health
needs of this patient population, we established the Lymphoma Epidemiology of Outcomes (LEO) cohort study,
which by June 2020 will have enrolled over 13,000 NHL patients and have <1% lost to follow-up. The LEO
cohort supports multiple grants and has generated novel and high impact findings on NHL prognosis and
survivorship. To continue and expand the key contributions of LEO, in this renewal we propose to: 1) Extend
recruitment at all 8 LEO centers, with a goal of recruiting 3400 newly diagnosed NHL patients focused on
Hispanic (N=900), African American (N=580), and Asian (N=200) participants (doubling the current sample
size for these groups) and adolescent and young adult (AYA) participants age 18-39 years (N=870; 87%
increase), and non-metro and rural patients of all ages and race/ethnicities (N=1,208, 72% increase), for a total
cohort of 16,500 patients; 2) Review all pathology diagnoses and maintain a NHL tumor bank that includes an
H&E slide, formalin-fixed, paraffin-embedded tissue samples in a tissue microarray, and extracted tumor DNA
and RNA; 3) Collect a peripheral blood sample and maintain a central biorepository of DNA, serum, plasma
and buffy coat; 4) Annotate and harmonize all cases with clinical, epidemiologic, pathology and treatment data,
including development of new informatics enhancements to capture clinical data from electronic health records,
digital pathology images and linkage to public databases to enhance data on environmental exposures and
socioeconomic factors; 5) Prospectively follow patients in the cohort to ascertain disease progression/relapse,
retreatment, transformation, second cancers, survival (including cause of death), updated exposures, patient-
reported outcomes (PROs), and other long-term health outcomes; and 6) Facilitate research projects that use
this infrastructure, promote interactions with NCI-supported clinical trials networks, patient advocacy groups,
and other collaborators. The goal of this Early-Stage Investigator Diversity Supplement is to improve
treatment decision-making and reduce the burden of treatment for older adults with indolent
lymphoma. We will achieve these aims through close coordination of each of the participating centers,
supported by four cores (Administration; Clinical; Pathology & Biospecimens; and Biostatistics & Informatics).
The LEO cohort is an exceptional resource that supports a broad research agenda aimed at identifying novel
clinical, epidemiologic, germline genetic, tumor, and treatment factors that influence NHL prognosis and
survivorship focusing on NCI research priorities in AYA, minority, and rural populations. LEO is led by
international experts in clinical and epidemiologic research on NHL, thereby driving the translation of new
findings to the clinic and the population.

Public health relevance
PROJECT NARRATIVE NHL is the most common hematologic malignancy, and there are many unmet clinical and public health needs of this growing patient population. The goal of this infrastructure grant is to support a cohort of over 16,000 non-Hodgkin lymphoma (NHL) patients in order to address broad and cutting-edge research that identifies clinical, epidemiologic (including lifestyle and other exposures), host genetic, tumor, and treatment factors, and the interaction among these factors, on short and long-term outcomes. The efforts of this Supplement are well aligned with the ultimate goal of identifying new approaches to improve the survival and well-being of NHL patients.